Structural Basis for Chemokine Function

PROJECT SUMMARY/ABSTRACT OF THE RESEARCH PLAN
The goal of this project is to understand how chemokines bind and activate their cognate G protein-coupled
receptors (GPCRs) to aid in development of new molecules that alter chemokine signaling for therapeutic
benefit. With 46 chemokine ligands and 23 receptors, the human chemokine network represents the largest
GPCR family with respect to the number of endogenous ligands and receptors. Chemokine-receptor specificity
varies from strictly monogamous to highly promiscuous, as illustrated in the accompanying illustration. This
"selectively promiscuous" signaling network orchestrates the trafficking of leukocytes and other cells in early
development, homeostasis and immune responses. GPCRs are well
represented in the pharmacopeia and many chemokines have been validated
as therapeutic targets, yet only three drugs in this category are approved for
clinical use. Biopharma companies and investors suspect that functional
redundancy makes the chemokine family effectively undruggable. I posit that
promiscuous chemokine-GPCR interactions have non-redundant functions in
the mammalian immune system, and that a full understanding of selective
promiscuity is essential for successful therapeutic development.
As a first aim for the continuation period of this MERIT award, I propose to
create The Chemokine Atlas as a comprehensive online resource linking all
details of sequence, 3D structure, and quantitative molecular pharmacology
for the entire human chemokine network. Using ortholog/paralog
conservation and contact network analysis of available structures, we
classified each chemokine and GPCR sequence position according to its
contribution to ligand-receptor selectivity. We will populate the Atlas with
high-quality homology models for every chemokine-GPCR pair and leverage
productive collaborations with Andy Chevigne (Luxembourg Institute of
Health) and industry partner Protein Foundry to carry out systematic all-by-all
functional profiling of the chemokine network. Guided by standardized
potency and efficacy values for G protein and B-arrestin signaling, we will
work with Aashish Manglik (UCSF) to develop a streamlined process for
purification and cryoEM structure determination of all functionally relevant
chemokine-GPCR pairs.
Aim 2 will test the hypothesis that 2D NMR is a sensitive tool for GPCR
pharmacotyping. Ongoing NMR studies of the conformational dynamics of
atypical chemokine receptor 3 (ACKR3) activation and inhibition will be
expanded to include several types of non-chemokine ligands. Engineered
nanobodies, synthetic and endogenous opioid peptides (recently discovered
to be ACKR3 ligands by the Chevigne group), and photoswitchable small
molecules from the lab of Rob Leurs (VU Amsterdam) will be compared to
NMR spectral signatures of chemokine agonist, nanobody antagonist and
unliganded receptor. We will identify NMR signatures that discriminate
between the binding of ACKR3 superagonists, full agonists, partial agonists, antagonists and inverse agonists.
To delineate G protein- and B-arrestin-specific conformational dynamics, the NMR activation and inhibition
profiles of chemokine receptors CXCR3 and CXCR4 will be compared with B-arrestin-biased ACKR3.
Our third aim will test the hypothesis that an ACKR3 nano body antagonist can be converted to an agonist
using a structure-guided design process. Our solved NMR structure, mutational analysis, and homology
modeling suggest that the extended CDR3 loop of VUN701 (from Martine Smit, VU Amsterdam) is a stable Bhairpin
that occupies the chemokine binding pocket and makes specific contacts that prevent ACKR3
activation. We will solve cryoEM structures of ACKR3-nanobody complexes to validate our mechanistic
models. Functional redesign of VUN701 will establish this nanobody as a development scaffold for GPCR
research tools or drug candidates with tunable pharmacology and programmable target selectivity.

Public health relevance
Project Narrative Chemokines and their cell-surface receptors form a network of signaling proteins that guide the homing and migration of white blood cells, stem cells and metastatic cancer cells to specific organs and tissues. These distinct and overlapping processes are controlled by the coordinated and non-redundant effects of dozens of different chemokine-receptor pairs, despite the extremely high similarity of all 46 human chemokines and an equivalent level of similarity for the 23 receptors. Our goal is to use advanced computational tools and experimental studies to decipher the 'chemokine code' that determines which receptor-ligand combinations orchestrate cell migration in the human body.